Molecular Mechanism of Glucocorticoid Receptor, Cytochrome P450, and P-Glycoprotein Axis on Drug Regulation at the Blood-Brain Barrier in Epilepsy with Focal Cortical Dysplasia

ABSTRACT
Pharmacoresistance to antiseizure medications (ASMs) is a major clinical challenge in effective seizure
management for nearly one-third of patients with epilepsy, where the blood-brain barrier (BBB) plays a
fundamental role. Most ASMs are substrates of the cytochrome P450 (CYP)/P-glycoprotein (Pgp) pathway,
which is transcriptionally regulated by glucocorticoid receptor (GR). We previously discovered a pivotal role for
local ASM metabolism, involving CYP drug-metabolizing enzymes and efflux transporters that impede drug
bioavailability across the epileptic BBB. A multiple-hurdle mechanism and its involvement of the GR-CYP-Pgp
axis in the human epileptic brain has been recognized, however, there remains an unmet need to establish GR
as a promising target to improve ASM bioavailability across the epileptic BBB. Our key findings suggest: 1) the
GR-mediated mechanism in human epileptic brain endothelial cells (ECs) regulates other nuclear receptors and
CYP-Pgp-affected drug bioavailability; 2) Novel GR and heat shock protein (Hsp) interactions (GR-Hsp) enable
accelerated GR maturation in human FCD brain tissues; and, 3) Cortical dysplasia with seizure induction in rats
resulted in brain GR upregulation and decreased BBB tight junction protein levels; reversed with GR inhibition
and, further, both alleviated seizure activity and increased oxcarbazepine bioavailability to the brain. Thus, it
becomes imperative to explicitly study GR as potential therapeutic target to improve ASM efficacy.
We will test the central hypothesis that GR modulation will improve ASM bioavailability across the
BBB by decreasing CYP-Pgp function in the dysplastic brain, to aid in preventing seizures and
epileptogenesis. To address this hypothesis, we will use a multi-modular approach (ex vivo, in vitro and in vivo).
In AIM 1 of the proposal, by comparing well-characterized specimens from dysplastic to non-dysplastic brain
regions, we will study the GR-CYP-Pgp axis, ASM bioavailability, and the effect of GR modulation in a
homogeneous patient population with a common drug-resistant epilepsy etiology. This will be compared to ASM
levels in drug responders (e.g. non-epileptic), with or without GR modulators. We will test the hypothesis that
modulation of GR in the human neurovasculature improves free brain ASM levels in epilepsy. The GR modulatory
effect will be additionally correlated to clinical and demographic characteristics, facilitating eventual clinical
transition. In AIM 2, the hypothesis will test if pharmacological modulation of GR in dysplastic ECs improves both
BBB properties and ASM penetration across the patient-specific in vitro BBB model. In AIM 3, we will test the
hypothesis that GR upregulation during epileptogenesis in CD rats, could be reversed by a combination of GR
modulators and ASM. The effect of GR agonists and/or inhibitors on ASM levels across the epileptic BBB will be
evaluated at each AIM. The proposed research will reveal the GR regulatory mechanism in dysplasia by
repurposing existing medications, which will be significant in improving brain ASM efficacy and
penetration across the BBB, in epilepsy.

Public health relevance
NARRATIVE Failed antiseizure medication (ASM) responsiveness is a major clinical challenge in more than one-third of patients with epilepsy, and we recently identified the glucocorticoid receptor (GR) controls key regulators of local drug biotransformation, functionally active in the blood-brain barrier (BBB) of epileptic brain endothelial cells. By modifying GR function in these brain endothelial cells, we could increase ASM penetration across the BBB and improve drug efficacy. In the proposed study, we will investigate the role of the GR-drug regulatory mechanisms at the BBB post-GR modulation, in patients with focal drug-resistant epilepsy due to cortical dysplasia (FCD) and compare with drug responders, while simultaneously using a rodent model of CD to identify novel GR mechanistic findings that will better manage seizures and/or prevent disease progression by repurposing existing medications; a step closer to a patient cure.